STUDIES OF IATROGENIC CANCER AND RADIATION DOSIMETRY

Evaluate the risk of developing second cancers in persons therapeutically treated with radiation and drugs. The goal of these studies is to quantify the risk of second cancer development by radiation dose and/or drug dose in several uniquely defined populations at the M. D. Anderson Hospital.